Intrinsic Ribosomal Decoding Center Methylation and the Bacterial Antibiotic Response

PROJECT SUMMARY/ABSRACT
Bacterial antibiotic resistance is a substantial public health threat, currently responsible for more than one million
deaths globally and predicted to escalate dramatically in the coming decades. As multidrug resistant strains
continue to emerge, it is imperative that we identify new antibiotic targets, design new antibiotics, and/or find
ways to resuscitate the activity of existing drugs for which resistance has become widespread. For example, the
aminoglycosides are a historically important class of ribosome-targeting antibiotics whose use is threatened by
both well-established mechanisms (e.g. aminoglycoside modifying enzymes) and the more recent emergence of
acquired aminoglycoside-resistance 16S rRNA methyltransferases. This latter group of enzymes chemically
modify the 16S rRNA in the ribosome decoding center (where mRNA is decoded) in the small ribosomal (30S)
subunit, conferring resistance to entire classes of aminoglycosides, including the most recently approved drugs
(e.g. plazomicin). Identifying ways to counter this mechanism of aminoglycoside resistance is thus of paramount
importance. In addition to being the target of the acquired aminoglycoside-resistance methyltransferases, the
ribosomal decoding center is also modified by intrinsic (housekeeping) methyltransferases which may also
influence aminoglycoside action. Loss of the intrinsic methyltransferases RsmH and RsmI, for example, is
associated with increased susceptibility to aminoglycosides. However, we currently do not know how these two
enzymes recognize the 30S subunit to methylate the same target residue (16S rRNA C1402), the full extent of
how they influence aminoglycoside susceptibility, and whether they impact aminoglycoside-resistance
methyltransferase activity and thus the resistance these acquired enzymes confer. In this project, I will test my
overall hypothesis that loss of methylation of C1402 by RsmH and RsmI induces rRNA structural
rearrangements that both increase aminoglycoside susceptibility and reduce resistance
methyltransferase activity. I will test this hypothesis through the following three complementary Specific Aims.
Aim 1–I will determine the mechanism of dual C1402 modifications by RsmH and RsmI using high resolution
cryo-EM studies complemented with mutagenesis studies and in vitro methylation assays. Aim 2–I will define
how C1402 modifications influence aminoglycoside susceptibility for a broad panel of aminoglycosides using a
combination of microbiological assays along with high-resolution structural studies and molecular dynamics
simulations. Aim 3–I will define the effects of C1402 methylation on acquired aminoglycoside-resistance
methyltransferase activity and ability to confer resistance using in vitro methylation assays in addition to a range
of microbiological studies. Defining how RsmI and RsmH function and how they influence aminoglycoside
susceptibility and resistance will enhance our understanding of intrinsic decoding center methyltransferase
mechanism of action and the role they play in bacterial aminoglycoside response. Such insights can serve as a
basis for future antimicrobial drug development and for exploring strategies to revitalize use of older antibiotics.

Public health relevance
NARRATIVE The increasing ability of bacteria to evade the effects of antibiotics is a significant global health crisis. This project will investigate how RNA modifying enzymes place their chemical modifications on a key bacterial antibiotic target (the ribosome) to alter antibiotic susceptibility and resistance. These studies will increase our understanding of how such RNA modifications influence the bacterial antibiotic response and could support future development of new therapeutic strategies to help counter the threat of bacterial antibiotic resistance.